Prefrontal neural modulation to restore cognitive deficits in an Alzheimer's Disease rat model

Project Summary
Alzheimer’s disease (AD) is characterized by memory impairments and underlying neuropathology, including
plaques, amyloid-β peptides, tau, in conjunction with neuroinflammation, and neuronal injury/loss, particularly in
the medial temporal lobe. Recent studies, however, suggest neurophysiological alterations in the prefrontal
cortex (PFC) evident in AD patients prior to gross neuropathology which may contribute to deficits in cognitive
processing early in AD. Given that the PFC contributes to top-down control of memory processing necessary
for optimal decision-making, dysfunction within the PFC may contribute to suboptimal decision-making which
often precedes gross memory loss in AD patients. Optimal decision-making requires functioning working memory
processes (i.e., using information “online” to guide choices) and flexible behavior (the ability to shift behavior in
response to changing consequences). Critically, early-stage AD may target brain circuits that underlie these
prefrontal dependent processes leading to early impairment in optimal cognitive processing. As such,
understanding neural circuits that are affected in AD underlie complex cognitive deficits may lead to earlier and
effective screening for AD risk and serve as an important therapeutic target for improving the quality of life AD
patients. The rat prelimbic cortex (PrL) is heavily implicated in working memory and flexible behavior necessary
for online decision-making. AD rats that were developed to show age-dependent neuropathological signatures
(plaques, tau) consistent with AD are impaired in PrL-dependent cognitive tasks prior to accumulation of
neuropathology. Critically, these deficits in PrL-dependent tasks precede behavioral deficits in other memory
tasks that do not depend on PrL function. As such, targeting the PrL function in vivo may restore these cognitive
processes in the AD rat model. Here, we aim to use noninvasive brain stimulation that modulates neural
oscillations to restore PrL-hippocampal neural activity (Aim 1) and PrL-orbitofrontal cortex neural activity (Aim 2)
in working memory (delay nonmatch to position task) and flexible behavior (reversal learning), respectively.

Public health relevance
Project Narrative Alzheimer’s disease (AD) is linked to progressive cognitive function loss and significant neuropathology across the brain including the prefrontal cortex and hippocampus. This proposal aims to use a transgenic rat model that recapitulates AD pathology to determine if neuromodulation of the prefrontal cortex restores early cognitive deficits and underlying neural dysfunction in this AD rat model.